Learning Health System Core

LEARNING HEALTH SYSTEM CORE SUMMARY
The Pediatric Center of Excellence in Nephrology (PCEN) at the Children's Hospital of Philadelphia (CHOP) is
designed to accelerate evidence generation in childhood kidney diseases through infrastructure that helps
overcome the many challenges to conducting rapid and efficient clinical research studies. PEDSnet, a growing
multi-specialty network of nine of the nation's largest pediatric academic health systems, has harmonized their
diverse electronic health record (EHR) systems to develop a national architecture to rapidly implement learning
health systems (LHS) across all pediatric health conditions. The LHS Core of the PCEN has partnered with
PEDSnet to establish a national interconnected, multi-institutional infrastructure able to reach large numbers of
children with kidney disease and to provide the depth of information necessary to comprehensively characterize
their clinical course and outcomes and to evaluate therapies. The LHS Core takes advantage of the expertise
and infrastructure developed during the construction of PEDSnet to provide methodologic, informatics, and study
development support to Center investigators and to expand the broad PEDSnet database to meet the needs of
PCEN-sponsored studies. The embedded Pediatric Nephrology Data Resource achieves both scale and
efficiency for EHR data currently being collected on over 8 million children with an emphasis on data elements
and data quality optimization central to studies of pediatric kidney disease.
In order to accelerate evidence generation and advance evaluations of interventions in pediatric nephrology, the
LHS Core will: expand and facilitate access to pediatric- and kidney-specific structured data in the Pediatric
Nephrology Data Resource and produce annual clinical insight reports for childhood kidney disorders; stimulate
and support high quality observational studies using the Pediatric Nephrology Data Resource by providing
technical and methodological resources to investigators; and expand Core services to enhance infrastructure for
comparative effectiveness research and pragmatic clinical trials in pediatric nephrology and leverage this
infrastructure to decrease time to trial implementation. In addition to providing access to this unique data
resource, LHS Core services will include computable phenotyping, augmented structured data and variable
definitions relevant to pediatric kidney disease, an active chart review program, patient-reported outcomes and
survey administration, data science and methodological consultation, self-service query tools, privacy preserving
linkage to other data resources, connection to pediatric nephrology and urology LHS initiatives, rapid
administrative start-up, prep-to-trial services, a multi-institutional kidney biopsy registry, real-world data for
external control matching, and EHR-facilitated recruitment. The Core team comprises expertise in data science,
epidemiology, health services research, and patient-centered outcomes. The Core has forged an organizational
and leadership architecture, created a uniquely valuable data resource, and developed an infrastructure that
makes cross-institutional collaboration amongst investigators in pediatric nephrology research routine.